Far Red Light to Improve Functioning in PAD: the LIGHT PAD Trial

Far Red Light to Improve Functioning in PAD: the LIGHT PAD Trial
Lower extremity peripheral artery disease (PAD) affects 10-15% of people age 65 and older and 15 to 20%
of those age 75 and older. Older people with PAD have greater functional impairment, faster functional
decline, and higher rates of mobility loss than people without PAD. In PAD, reduced perfusion of
gastrocnemius muscle is associated with increased gastrocnemius oxidative stress, mitochondrial impairment,
and muscle fiber damage. Yet few non-invasive therapies improve functioning in people with PAD.
Nitric oxide (NO) is a signaling molecule with therapeutic properties that improve perfusion and reverse the
skeletal muscle pathology in PAD. In preclinical studies, NO increases angiogenesis and perfusion, protects
against ischemic injury, enhances skeletal muscle mitochondrial activity, and activates satellite cells, which
restore and repair skeletal muscle. Interventions that increase NO bioavailability have major therapeutic
potential for people with PAD.
Nitrosothiols are a major source of NO and NO bioactivity. Preclinical studies and our preliminary human
evidence show that far red light (at wavelength of 670 nm) releases nitrosothiols, nitrite, and other vasoactive
species. Four pilot studies completed in preparation for this proposal showed that a single dose of far red light
therapy increased plasma nitrosothiols, improved lower extremity blood flow, and meaningfully improved
functional performance in people with PAD.
Therefore, we propose a Phase II randomized clinical trial to collect preliminary data to test whether four
months of daily far red light treatment of the lower extremities improves walking performance, lower extremity
perfusion, and ischemia-related gastrocnemius muscle damage in people with PAD, compared to a sham
control. Thirty- two people with PAD will be randomized to 10 minutes of daily home treatment with either far
red light or a sham light for four months. Our primary outcome is change in six-minute walk distance at 4-
month follow-up. In secondary and exploratory aims, we will distinguish between acute and chronic effects of
far red light on six-minute walk, measure the effects of far red light on treadmill walking performance and
patient-reported outcomes, and delineate biologic pathways by which far red light improves walking
performance in PAD, by measuring change in plasma nitrite and nitrosothiols, gastrocnemius muscle perfusion
(MRI arterial spin labeling) and gastrocnemius muscle health and mitochondrial activity (measured by muscle
biopsy). If our hypotheses are supported by this Phase II trial, results will be used to design a definitive
randomized trial of far red light for people with PAD. If far red light improves functional performance in PAD,
this simple, accessible, and well tolerated therapy will have a major impact on preventing mobility loss and
improving quality of life in the large and growing number of older people disabled by PAD.

Public health relevance
PROJECT NARRATIVE Older people with lower extremity peripheral artery disease (PAD) have greater walking impairment and faster functional decline than those without PAD. Yet few therapies have been identified that improve disability in people with PAD. This randomized clinical trial will collect preliminary evidence to determine whether far red light therapy of the lower extremities improves walking impairment in older people with PAD, compared to a sham light device. If our hypotheses are correct, results will be used to design and conduct a large clinical trial of far red light therapy for PAD.